Airspace Candida Colonization and Lung Injury (AirCCoLIN)

PROJECT SUMMARY – ABSTRACT
Candida species are frequently detected in lower respiratory tract (LRT) samples from critically ill patients on
mechanical ventilation, yet their role in contributing to lung injury remains poorly understood. Traditionally
regarded as benign colonizers, emerging evidence now suggests that Candida in the LRT may actively disrupt
lung barrier integrity, potentially exacerbating lung injury and impacting clinical outcomes. Our data, along with
other studies, demonstrate that high C.albicans abundance is associated with increased inflammation, lung
injury markers, and mortality in these patients. Elevated levels of neutrophil elastase and epithelial injury
markers in individuals with Candida colonization indicate that Candida may drive acute lung injury by triggering
intense neutrophilic inflammation and epithelial disruption. Additionally, in mouse models, we show that
intratracheal (i.t.) C.albicans instillation significantly disrupts lung barrier function, with co-exposure to
lipopolysaccharide (LPS) amplifying injury—a clinically relevant two-hit model mimicking acute respiratory
distress syndrome (ARDS). One plausible mechanism involves the Dectin-1 receptor, which recognizes fungal
beta-D-glucan. Genetic variation in Dectin-1 is linked to differential lung injury outcomes, and preliminary data
reveal that Dectin-1 knockout mice exhibit reduced neutrophil recruitment and lung damage, highlighting
Dectin-1’s potential role in modulating host injury responses. Additionally, C. albicans virulence factors, such
as hyphal formation and candidalysin secretion—established mediators of epithelial damage in mucosal
candidiasis—induce significant cytotoxicity and barrier disruption in the lung epithelium, particularly in strains
that transition to hyphal forms. Our findings suggest that C. albicans promotes lung injury via two principal
mechanisms: (1) by escalating neutrophil-mediated lung injury and (2) by direct epithelial barrier disruption
driven by fungal virulence factors. The Airspace Candida Colonization and Lung Injury (AirCCoLIN) study
addresses these questions by investigating the impact of host susceptibility, Dectin-1 receptor signaling, and
C. albicans virulence factors on lung injury across in vitro assays, mouse models, and human LRT specimens.
Aim 1 will delineate host factors, particularly susceptibility and Dectin-1 receptor signaling in neutrophils, that
contribute to C.albicans-induced lung injury. Aim 2 will focus on pathogen factors, assessing the impact of C.
albicans virulence factors on epithelial barrier integrity and neutrophil responses in both in vitro and in vivo
models of lung injury. Aim 3 will identify clinical and molecular predictors of lung injury in ventilated patients
colonized with C.albicans in the LRT. Successful completion of the AirCCoLIN study will define novel host-
pathogen interactions in the setting of acute lung injury and repair, positioning C. albicans as a potential
modifiable target for reducing lung injury in critically ill patients with acute respiratory failure. Given C.albicans'
designation as a critical priority pathogen by the World Health Organization, this research could inform
innovative therapeutic approaches to mitigate lung injury in this vulnerable population.

Public health relevance
PROJECT NARRATIVE The Airspace Candida Colonization and Lung Injury (AirCCoLIN) study seeks to determine the clinical significance of C.albicans colonization in the lower respiratory tract of critically ill patients on mechanical ventilation. Our preliminary findings suggest that C.albicans correlates with increased mortality and prolonged ventilation, while experimental models show it exacerbates lung injury and disrupts epithelial barriers. Through a comprehensive study plan integrating in vitro, in vivo, and human translational research, this project aims to uncover the mechanistic and clinical significance of C.albicans-induced lung injury and assess whether C. albicans colonization is a modifiable target for improving outcomes in patients with acute respiratory failure.